Administrative Core (AC)

PROJECT SUMMARY - ADMINISTRATIVE CORE
The Administrative Core (AC) will provide a structure to facilitate effective and integrative interactions between
the TCORS team. The AC will ensure all programmatic activities focus on achieving the overall goal of the Center
– using our integrative theme, “Flipping the Script”: Using the Industry's Nicotine Playbook to Maximize
Public Health, to understand how industry nicotine manipulations in electronic cigarettes (ECs) and oral nicotine
pouches (ONPs) are impacting product appeal, addictiveness, use patterns, and toxicity. The resulting data will
inform effective product standards and marketing regulations on nicotine manipulations with the intent to
dissuade young people, including non-users, from using ECs and ONPs, but still provide a satisfying and less
harmful alternative for adult tobacco users (smokers and smokeless tobacco users) who completely switch to
these products. The AC will foster and promote the goals of each component (cores and projects) by providing
scientific direction, administrative support, oversight, and integration of Center activities to ensure operational
efficiency. The Specific Aims of the AC are to: 1) Provide overall research direction and center oversight by
setting the research agenda focused on determining how manipulation of nicotine and aspects of product
packaging, impact product appeal, addictiveness, and toxicity; 2) Promote communication and integration within
the Center as well as promote interaction between other funded TCORS, the Center for Coordination of Analysis,
Science, Enhancement, and Logistics (CASEL), the Center for Rapid Surveillance of Tobacco (CRST), and the
FDA and NIH staff; 3) Coordinate and organize committee structure and communications, and ensure operational
efficiency for all projects, pilot studies and cores of the center; and 4) Foster dissemination of tobacco regulatory
research findings, including data sharing. For this last aim, the Translational Tobacco Policy Team (TPT) will
have oversight and provide critical input ensuring research data has translational impact to inform effective
tobacco policy. The AC will ensure that all components of the Center work seamlessly together to accomplish
the overall and component-specific goals of this Center. The resulting data from our center projects will inform
effective product standards and marketing regulations on nicotine dimensions that dissuade young non-users
from using ECs and ONPs but still provide a satisfying and less harmful alternative for adult tobacco users.